Identifying Upper Motor Neuron Pathology and Molecular Signatures in the Amyotrophic Lateral Sclerosis (ALS) Motor Cortex

Abstract
Dr. Frank Diaz is a neurologist and neuromuscular medicine specialist interested in identifying and understanding
the pathophysiology of the motor cortex and upper motor neurons in patients with amyotrophic lateral sclerosis
(ALS). Since ALS is a very heterogeneous disease without ideal animal models, Dr. Diaz’s goal is to develop
additional skills to become an independent physician-scientist and develop a translational research program that
will combine longitudinal clinical measures, in vivo magnetic resonance imaging measures, and postmortem
imaging and transcriptomics to identify underlying pathophysiological mechanisms in ALS. For Aim 1, Dr. Diaz
proposes to use advanced iron-sensitive MRI techniques in vivo and postmortem to identify the pathological
substrate and clinical significance of “the motor band sign”, a promising marker of motor cortex pathology in ALS
patients. The goal is to first determine the correlation of upper motor neuron degeneration, TDP-43 pathology,
microgliosis/ astrogliosis, and iron with the MRI motor band sign in the hand knob area of postmortem brains. To
do so, Dr. Diaz proposes to develop and use novel 3D-printed custom brain sectioning templates for accurate
imaging-pathological correlations. To understand the clinical significance, he proposes to image the motor band
sign in vivo and longitudinally in patients with classic ALS, ALS variants with different degrees of clinical upper
motor neuron involvement, and controls, and determine the correlation with clinical measures of upper motor
neuron involvement, and disease progression. The goal of Aim 2 is to identify motor cortex and upper motor
neuron-specific molecular signatures from the hand knob area of patients with ALS. To do so he proposes to
first generate a single nucleus RNA sequencing (snRNA-seq) dataset from readily available frozen specimens
from patients with classic ALS and controls. However, since the clinical data from available samples is limited,
to determine molecular signatures associated with clinical upper motor neuron dysfunction, he proposes to
collect the brains from patients in Aim 1, perform snRNA-seq postmortem, and compare the molecular signatures
from patients that in vivo had evidence of upper motor neuron dysfunction those without clinical evidence of
upper motor neuron dysfunction. These studies will identify novel targets of motor cortex and upper motor neuron
dysfunction for drug development. In addition, the motor band sign could develop into a non-invasive imaging
biomarker for early identification of upper motor neuron dysfunction and/or for monitoring drug efficacy. Dr. Diaz
will be supported by his primary mentor, Dr. Clive Svendsen, a leader in ALS research, as well as his co-mentor
Dr. Pascal Sati, an expert on MRI, and a multidisciplinary advisory committee that will provide the expertise and
training necessary in advanced MRI applications, imaging-histological correlations, and transcriptomics. The
long-term research goals are to address important and complex questions in ALS, such as the temporal and
spatial progression and spread of the disease and identify early vs. late pathophysiological markers of disease
using a combination of clinical measures, MRI, and transcriptomics in the same patients in vivo and postmortem.

Public health relevance
Project Narrative ALS, the most common motor neuron disease, is a neurodegenerative condition that results in progressive weakness and ventilator-dependence or death within 3-4 years from onset and has no cure. The motor cortex is known to play an important role but little is known about its pathophysiology. The proposed studies have the potential to identify novel targets of upper motor neuron dysfunction for drug development, and could result in the development of a non-invasive imaging biomarker for early identification of upper motor neuron dysfunction and diagnosis.